Basic and Translational Science Core

PROJECT SUMMARY FOR BASIC AND TRANSLATIONAL SCIENCE CORE
The Basic and Translational Science Core is the major scientific core supporting the breadth of basic and
translational research across the UCSF-Bay Area Center for AIDS Research (CFAR). This new encompassing
Core is a product of our strategic planning process, which involved soliciting input from key stakeholders in the
CFAR community. The Core consists of two continued and enhanced Sub-Cores including Immunology and
Functional Genomics (formerly the Immunology Core) and Pharmacology of Cure and Pathogenesis (formerly
the Pharmacology Core) as well as a new Bioinformatics Sub-Core. The Immunology and Functional
Genomics Core broadens the focus of the prior flow cytometry-based Immunology core by adding both high-
dimensional spectral flow cytometry and scRNAseq support. The Pharmacology of Cure and Pathogenesis
core focuses pharmacology support on the needs of CFAR investigators for pharmacokinetic (PK) and
pharmacodynamic (PD) studies for studies of putative cure interventions. The Sub-Core also provides tissue
drug levels, and measurement of drugs and metabolites relevant to pathogenesis and co-morbidities. This
enhanced focus complements the Biomarkers of Behavior Program in the Bio-behavioral Core, which
measures antiretroviral drug levels for adherence research. Given the consistent need expressed by basic and
translational investigators during our strategic planning process for bioinformatics support, we have also added
a new Bioinformatics Sub-Core in the Basic and Translational Core to support investigators in computational
high-dimensional data processing, analysis, visualization, and management of multi-omics data. Each one of
our Sub-Cores is integrated not just administratively, but also functionally connected through well-attended bi-
weekly “SCOPTIONS” (an interest group focused on HIV cure and inflammation) and monthly “Multi-Omics”
(an interest group relevant to bioinformatics) work-in-progress sessions, which support early stage
investigators (ESI’s) in the basic and translational sciences across all our campuses and affiliates. These two
interest groups also reinforce and grow community; spur multidisciplinary collaborations; and connect ESIs to
core services, senior investigators, mentorship, specimens and data for pilot awards, and CFAR leadership.
Finally, this Core is well integrated with the Developmental Core, through support of pilot awards and the
CFAR Mentoring Program for our basic/translational ESIs; with the Clinical Core through the SCOPE cohort;
and with the Bio-Behavioral Core through the Biomarkers of Behavior Program and the PrEP cohort. The Basic
and Translational Core will also work closely with the other Cores to ensure efficient use of CFAR resources to
address overall Center aims and crosscutting priorities of training/career development, equity/community
engagement, and international HIV research.